Admin Supplement for Retention of K Awardees: Contributions of Hypoglycemia and Hyperglycemia to Adverse Geriatric Outcomes in NH Residents

Project Summary/Abstract
Unchanged from K01AG073532

Public health relevance
Project Narrative Unchanged from K01AG073532